Teen Mothers’ Prenatal Cannabis Use and Co-Use with Tobacco

This is a proposal for an administrative supplement in response to NOT-OD-22-03: Notice of Special Interest
(NOSI): Research on the Health of Women of Understudied, Underrepresented and Underreported (U3)
Populations. Structural racism and discrimination (SRD) has been linked to adverse pregnancy outcomes
among Latine girls and women, especially those who identify as English language learners (ELL; also called
limited English proficient or non-English speaking) and immigrants. SRD create compounding challenges for
ELL Latine immigrant pregnant girls and women from emerging or “new growth” Latine communities that have
seen rapid growth and may lack the structural and social supports available in established Latine communities.
SRD may impact maternal and child health among adolescent and young adult (AYA) pregnant ELL Latine
immigrants by interacting with substance use, intimate partner violence (IPV), and depression, all of which are
prevalent in this group. In the proposed study, we will be pursuing the aims of the YoungMoms project
(R01046401) a mixed-methods longitudinal study of cannabis and tobacco use in AYA pregnant and
postpartum people in Pittsburgh. We will leverage our partnerships with community leaders at Casa San José
and the Salud Para Niños program to recruit pregnant and postpartum ELL immigrant Latine AYA to
contextualize SRD, IPV and depression in this underserved community and to adapt the YoungMoms protocol.
The YoungMoms project currently measures discrimination related to racism with the Everyday Discrimination
measure, as well as substance use, depressive symptoms and IPV. However, ELL Latine people, who are
under-represented in research, are currently excluded from the YoungMoms project because study materials
are only available in English. They also may have experiences that are not captured by the current
YoungMoms measures. We seek supplemental funding to achieve two aims: (1) conduct interviews with
postpartum ELL immigrant Latine ages 14-24 to better understand how SRD intersects with substance use,
IPV, and depression; and (2) use the Method for Program Adaptation through Community Engagement
process and human centered design to translate, pilot test, and refine the protocols and measures for the
YoungMoms study so that they are linguistically and culturally affirming for pregnant ELL immigrant Latine AYA
in Pittsburgh. This community-partnered research project will center the voices of this population with the use
of qualitative interviews and innovative community collaborative meeting activities. Results from this proposal
will inform expansion of recruitment for the YoungMoms study to also include Latine ELL people, advance our
understanding of how SRD impacts pregnant ELL Latine AYA, and establish tools and methods for further
research to promote the health and thriving of Latine people from emerging communities.

Public health relevance
This study takes a community-based and intersectional approach to examine the way racism, xenophobia, and language inaccessibility intersect to shape experiences during pregnancy and impact substance use, interpersonal violence (IPV), and depression in adolescent and young adult English language learning (ELL) Latine immigrants. We also seek to understand the supports and resources pregnant ELL immigrant Latine adolescents and young adults access, bringing a strengths-based lens to the work. We will leverage partnerships with trusted community partners and use an innovative human-centered design approach to adapt the YoungMoms protocol so that it is linguistically and culturally-affirming for pregnant immigrant ELL Latine adolescents and young adults so that this under-represented group can be recruited into the parent study.